Center for Genomic Information Encoded by RNA Nucleotide Modifications

SUMMARY: Post-transcriptional mechanisms control gene expression in virtually every cell. A major
mediator of post-transcriptional gene regulation is the translating ribosome, which comprises three different
types of RNAs: rRNA, tRNA and mRNA. These RNAs, along with ribosomal and mRNA-binding proteins, form
a multi-RNA/multi-protein complex that can markedly influence mRNA stability and translation. Importantly,
this complex is not constitutive. Instead, rRNA-tRNA, rRNA-mRNA, and tRNA-mRNA interactions are highly
regulated, although the mechanisms of its regulation are poorly understood. A potential mechanism may
involve chemical modification of their nucleotides. Indeed, rRNA, tRNA and mRNA are subjected to diverse
chemical modifications whose stoichiometry is highly regulated in different tissues or disease states. Our
underlying hypothesis is that the regulated nucleotide modifications in rRNA, tRNA, and mRNA act as a “code”
that controls these RNAs and their mutual interactions, thus encoding unique patterns of gene expression.
Although rRNA, tRNA, and mRNA nucleotide modifications are poised to be critical regulators of gene
expression, studying how these modifications influence each other to control gene expression has been
difficult to explore. In part this reflects the lack of scalable methods to quantify and profile nucleotide
modifications in rRNA, tRNA, and mRNA. Another problem is that understanding the interactions of rRNA,
tRNA, and mRNA requires specialized expertise in each of these three major areas of RNA biology. It is
therefore critical for experts in rRNA, tRNA, and mRNA to work together to decipher the mutual interactions of
these RNAs. The Center will bring together a team of experts in these diverse types of RNAs who will work
together to develop novel techniques to probe nucleotide modifications and how they interact to orchestrate
unique patterns of gene expression. The Center will develop novel technologies for mapping and quantifying
rRNA, tRNA, and mRNA modifications, identify the dynamic modification sites in tissues and disease, and
determine the function of these dynamic modifications. The methods and datasets that will be developed in
the Center will provide the foundational knowledge needed to accelerate new areas of epitranscriptomics
research in rRNA, tRNA, and mRNA biology. The Center has a major outreach and educational mission. The
outreach/educational opportunities will include sponsored undergraduate research, breakout project funding,
project funding for underrepresented minority trainees, funding for training visiting outside investigators, and
funding for an annual symposium. We will also develop a website that curates the epitranscriptomic mapping
data generated by the Center to ensure rapid and easy access to the new data we generate. Overall, the
Center’s mission is to serve as a hub for training researchers in epitranscriptomics, as well as to develop new
enabling technologies, develop foundational datasets, and reveal fundamental principles of modified nucleotide
function in rRNA, tRNA, and mRNA that are needed to open up new areas of epitranscriptomics research.

Public health relevance
PROJECT NARRATIVE Ribosomal RNA (rRNA), transfer RNA (tRNA), and messenger RNA (mRNA) are subjected to regulated and dynamic tissue-specific, signaling-specific, or disease-specific chemical modifications, many of which appear to regulate the fate and function of these RNAs. Although N6-methyladenosine (m6A) in mRNA comprises the major focus of the scientific community, other highly prevalent, and possibly similarly important, modifications in rRNA, tRNA and mRNA have not been studied in similar depth due to the lack the tools to quantify their precise stoichiometries in a site-specific and high-throughput manner. The Center for Quantitative and Site-Specific Analysis of RNA Modifications comprises an interdisciplinary and highly synergistic group of investigators who will develop a suite of enabling technologies that will provide the foundational tools, datasets, protocols, and concepts regarding modified nucleotide function, which will be needed to unravel the function of the still unresolved epitranscriptomic code in rRNA, tRNA, and mRNA.